Admin Core

ABSTRACT - ADMINISTRATIVE CORE
The Administrative Core of the Mayo Clinic American Joint Replacement Research Collaborative (AJRR-C)
provides support for the scientific and administrative work of the Methodology and Resource Cores and
expand the TJA research community with the overarching goal to accelerate innovative, high quality, high
impact, and interdisciplinary clinical research in TJA. The centralized research governance at Mayo Clinic
enables the Administrative Core to efficiently manage the administration of the AJRR-C. We leverage the
unique expertise, data and infrastructure resources of the Mayo Clinic as well as the national registry American
Joint Replacement Registry (AJRR) as the Resource Core.
The Executive Management Team focus on integration of the AJRR-C within the institution, ensures the quality
and efficiency of AJRR-C activities through administrative and scientific oversight, communication and
outreach efforts with professional societies and other stakeholders, and continuous improvement using robust
evaluation metrics. The Executive Management Team receives strategic input from the External Advisory
Committee composed of surgeons who are leaders in TJA clinical research, methodology experts and partners
from research databases. The Specific Aims of the Administrative Core are: (1) To provide leadership and the
overall organizational infrastructure to AJRR-C, strengthening its role as a national methodology hub for clinical
research in TJA, (2) To stimulate and oversee regional and national collaborations, (3) To oversee and ensure
the quality and efficiency of AJRR-C activities including pilot and feasibility studies and the fellowship program,
and (4) To evaluate key metrics for success related to all AJRR-C activities.

Public health relevance
NARRATIVE The Mayo Clinic American Joint Replacement Research Collaborative (AJRR-C) provides methodological expertise and access to nationwide data resources to facilitate innovative, methodologically rigorous, and interdisciplinary clinical research in TJA. The clinical research needs of the TJA research community that are addressed by the AJRR-C include training of the next generation of TJA researchers, customized consultations, facilitated access to high quality, rich data sources and national TJA registry data as well as informatics and methodology support.